The Cytokine Suppressor CIS in Giant Cell Pneumonitis

Project Summary
Giant cell pneumonitis (GCP) is a collection of fatal chronic diseases, including hard metal lung
disease, virus-associated GCP and non-hard metal, non-infectious GCP. Regardless of the
etiology, GCP is characterized by the presence of alveolar macrophage-derived multinucleate
giant cells (MGCs) that together with other immune infiltrates obstruct alveolar spaces and cause
lung failure. Little is known on the pathogenesis of GCP, which is largely due to lack of
appropriate animal models, and there is no effective treatment, presenting a critical knowledge
gap. In this proposal, we will close an aspect of this knowledge gap by using a unique animal
model of GCP we recently developed to investigate the immunological mechanisms that lead to
this fatal disease. Hard metal (such as cobalt) workers had elevated levels of serum IgE, a CD4+
T helper (TH) 2 cell-dependent antibody isotype, and patients with hard metal GCP contained
increased numbers of T cells in their bronchoalveolar lavage fluids (BALFs), implicating a
potential role of T cells in the pathology of GCP. However, it is entirely unclear how dysregulation
of TH cells causes MGC formation, resulting in the development of GCP. Our long-term goal is to
dissect the mechanisms underlying the pathogenesis of GCP; the discoveries may lead to novel
therapeutic options. The scientific premise of this proposal is strongly supported by our
preliminary studies that CIS, a member of the suppressor of the cytokine signaling (SOCS) family,
is required to suppress GCP, which is likely via a T cell-dependent manner; Cis-deficiency in mice
leads to formation and accumulation of MGCs with increased numbers of TH cells in the lungs
and causes severe obstruction of alveoli, leading to even death. Our central hypothesis is that CIS
inhibits MGC formation via restricting TH cell responses, therefore preventing GCP. The Specific
Aims are: Aim 1. Determine the TH cell-intrinsic role of CIS in the development of GCP. Aim 2.
Delineate the mechanism underlying the suppressive function of CIS in GCP, especially hard
metal lung disease.

Public health relevance
Project Narrative Giant cell pneumonitis (GCP) is a collection of fatal chronic diseases, which is characterized by the presence of alveolar macrophage formed multinucleate giant cells (MGCs) that together with other immune infiltrates obstruct alveolar spaces and cause lung failure. Little is known on the pathogenesis of GCP, which is largely due to lack of appropriate animal models, and there is no effective treatment, presenting a critical knowledge gap. In this proposal, we will close an aspect of this knowledge gap by using our unique animal model of GCP to investigate the immune mechanisms that lead to this fatal disease. Studies on patients with hard metal-caused GCP implicate a potential role of T cells in the pathology. Our preliminary studies demonstrated that CIS, a cytokine signal suppressor, inhibits T cell responses and is required to suppress spontaneous GCP in mice. We hypothesize that CIS inhibits MGC formation via restricting T cell responses, therefore preventing GCP. By address our hypothesis, this study will pave a novel avenue in understanding of GCP and may lead to new therapeutic opportunities. This work has clear biomedical relevance to human GCP.